ASSESSING FREQUENCY OF SKIN REACTIONS IN PATIENTS RECEIVING ANDRODERM

This randomized, multicenter, parallel group study will evaluate the efficacy of different pretreatment regimens (creams and moisturizers) in preventing known skin irritation from the Androderm patch.